Clinical Core

SUMMARY CLINICAL CORE
The Clinical Core of the Stanford Alzheimer’s Disease Research Center (ADRC) will enroll, assess, and follow
participants with Alzheimer’s disease (AD) or Lewy body disease LBD and healthy older adults without
cognitive or motor impairment. Participants are characterized by clinical syndrome and by biological disease
inferred from fluid and imaging biomarkers. Clinical Core aims are the following: 1) Enroll participants into
research protocols of the Stanford ADRC; characterize their neurological, cognitive, and behavioral status;
provide consensus diagnoses; provide high-quality clinical data to the Data Management and Statistical Core;
follow participants longitudinally; and promote adherence and retention. 2) Support deep phenotyping of ADRC
participants in coordination with Imaging, Neuropathology, and Biomarker Cores through clinical assessments,
biospecimen collections, and other means. 3) Assess hearing, vision, and olfaction as new Core resources. 4)
Support developmental projects and other research needs of investigators interested in AD and AD related
dementias. 5) Support the Research and Education Component by providing a rich training environment for
students, residents, fellows, and faculty.